FREQUENCY OF SYSTEMIC HYPERTENSION IN VARIOUS CARDIOVASCULAR DISEASES

This report summarizes the clinical frequencies of systemic hypertension and necropsy evidence of cardiomegaly in various cardiovascular conditions. Systemic hypertension is present in greater than 50% of patients with various coronary events, in greater than 75% of patients with various cerebrovascular events, and in greater than 90% of patients with aortic dissection. Hypertension is the sole underlying factor in most patients with nontraumatic cerebral arterial or aortic (dissection = partial rupture) rupture. In association with hypercholesterolemia (serum total cholesterolemia greater than 150 mg/dl), hypertension clearly accelerates atherosclerosis and its devastating consequences.